REGULATION OF SUGAR TRANSPORT AND METABOLISM IN LACTIC ACID AND ORAL BACTERIA

Microorganisms are causative or contributory agents in the etiology of dental caries, gingivitis and related periodontal disease(s). The pathogenicity of Gram-positive streptococci and Gram-negative Fusobacteria resides in part in the capacity of these species to form a variety of organic acids and toxic sulfur-containing derivatives as end products of carbohydrate and amino acid fermentation. Elucidation of the biochemical steps and the genetic basis for regulation of these energy-yielding pathways provides the rationale for this research program. Significant accomplishments of the past year include: 1) Demonstration that the triosephosphate gene (tpi) of Lactococcus lactis is monocistronic; 2) Elucidation of the role(s) of lysine 214 and cysteine residues in activity and cytotoxicity of beta-cystathionase from Bordetella avium; 3) Purification, cloning, sequence analysis and expression of maltose 6-phosphate:6-phosphohydrolase from Fusobacterium mortiferum ATCC 25557; 4) Cloning and site-directed mutagenesis of catalytically functional residues of Tn5306-encoded N(5)-(carboxyethyl) ornithine synthase from L. lactis; 5) Purification of a novel cellobiose 6-phosphate:6-phosphohydrolase from F. mortiferum; 6) Chemical synthesis of unique methylumbelliferyl analogs of phospho-alpha and phospho-beta-glucosides for use as fluorogenic reporter molecules for study of the regulation of gene expression in Fusobacteria. Results from this research program have been published in four papers in peer-reviewed, international journals.